PTH actions on early cells of the osteoblast lineage

Parathyroid hormone (PTH), whether administered intermittently to treat osteoporosis, or administered
continuously in rodent experiments, increases bone formation rate. While osteoblasts, osteocytes, and bone
lining cells contribute to the PTH response, the role of osteoblast precursors in the PTH response is poorly
understood. We have used expression of Sox9, a gene expressed in many stem cell types, to mark early cells
in the osteoblast lineage and to understand how PTH affects these cells. In Aim 1, we will determine the
signaling pathways inside osteoblast precursors that are activated downstream from the PTH receptor in order
to increase the number of these precursors. Because Gs, the heterotrimeric G protein, is an important
signaling relay downstream of the PTH receptor in mature osteoblasts and osteocytes, we will knockout Gsa in
Sox9-expressing osteoblast precursors and their descendants. Because mice with a mutant PTH receptor (so-
called DSEL receptor) that cannot activate Gq/11 have abnormal bone, we will determine whether PTH
increases the number of osteoblast precursors in DSEL receptor mice in the same way that PTH does in wild
type mice. Because salt-induced kinases (SIKs) are prominent regulatory targets of PTH signaling in
osteocytes, we will determine whether inhibition of SIKs is an important strategy downstream of activation of
Gsa in the PTH-induced increase in the number of osteoblast precursors. In Aim 2, we will address the
heterogeneity of the early cells of the osteoblast lineage. Osteoblast precursors can be found in the growth
plate, bone marrow, and periosteum. We will use lineage tracing in Aim 2A to determine whether growth plate
osteoblast precursors (marked with PTHrPcreERt) become Sox9-expressing cells in the marrow and whether
Sox9 marked cells become CXCL12-abundant reticular (CAR) cells in the marrow. Further, we have found
that Sox9-marked cells in the metaphysis, the endosteum and periosteum have strikingly different paths to
osteogenesis. To determine these paths, and also to compare Sox9-marked paths with those marked by
growth plate stem cells and marrow CAR cells, we will use single cell RNA sequencing in collaboration with Dr.
Alexandra-Chloé Villani, a leader in this field in Aim 2B. The characterization of the genetic makeup of
individual cells will allow us to define the variety of distinct fates of skeletal stem cells and the signaling
molecules/transcription factors that regulate these cells. In Aim 3, we will use these same methods to
determine how PTH increases the numbers of cells descended from skeletal precursors and how the cellular
pathways change when Gs signaling is blocked in these cells. Single cell RNA sequencing will be used to
determine the mechanisms downstream of the pathways established in Aim 1 that PTH uses to increase the
numbers of osteoblast precursors. Thus, we will clarify the relationships between the varieties of skeletal stem
cells and how PTH changes the pathways used by skeletal precursors.

Public health relevance
Parathyroid hormone (PTH) increases bone formation and, for that reason is used to treat osteoporosis. PTH increases bone mass partly by increasing the numbers of precursors of the bone-forming cell, the osteoblast. These precursors are found in bone marrow and are poorly characterized. We will isolate large numbers of osteoblast precursors and determine the sequences of the genes expressed in individual precursor cells both at baseline and after administration of PTH. We will also determine how the receptor for PTH signals in precursor cells. With this information, we should have a rational basis for developing new strategies to increase bone mass in humans.